Investigating Functional Outcomes and Cognition thrU Surgery (InFOCUS) study

Project Summary
Cognitive decline with aging, including Alzheimer’s Disease and Related Dementias (ADRD), is a public health
imperative that impacts quality of life and disability. Survivors of acute surgical or medical illness contribute
greatly to the crisis of cognitive decline. Hospitalization confers a 1.5-2-fold increase in the odds of new onset
dementia. Surgery is common in older adults, but it (and its resulting hospitalization) is associated with
significant cognitive decline. Individual interventions to reduce this decline have exhibited limited success. The
COgnitive and Physical Exercise to improve Outcomes after Surgery (COPE-iOS) study is evaluating a
program of cognitive and physical training throughout the perioperative period. The intervention consists of
adaptive computerized cognitive training plus guided aerobic exercise sessions, whereas the active attention
control consists of a non-adaptive control computer game and guided stretching sessions. Comprising both
prehabilitation and rehabilitation, the two study arms participate in activities for at least 2 weeks prior to surgery
and for 3 months after discharge and involve significant weekly interaction with our study team. The study
assesses global cognition, disability, depression, and mechanistic pathways. Multiple additional factors,
including social support, may influence postoperative recovery, and organized support groups empower
patients are associated with improved outcomes after surgery. Throughout the COPE-iOS study, participants in
both arms consistently engage with a core team of personnel and sessions are group-based, allowing
participants to engage with and support one another. This design provides a much higher level of interaction
with providers and peers facing similar circumstances than standard perioperative care. While the active
attention control design is essential to the COPE-iOS study to evaluate the efficacy of the cognitive and
physical exercise program, the active attention control may confer more benefit to patients than previously
anticipated. The Investigating Functional Outcomes and Cognition thrU Surgery (InFOCUS) study is a
prospective observational cohort measuring cognitive and physical outcomes after major surgery in older
adults who are receiving usual care. The primary hypothesis of this proposal is that outcomes in usual care will
be worse than both a combined cognitive and physical exercise program and an active attention control
program with regard to global cognition (Aim 1) and disabilities and depression (Aim 2). The InFOCUS study
will enroll 125 patients ≥60 years old awaiting major inpatient surgery and assess global cognition, activities of
daily living, and depression at baseline and at 3 and 12 months after discharge to allow better understanding of
the efficacy of the combined cognitive and physical exercise program and further our knowledge on potential
contributions of enhanced systemic support around major surgery to improve outcomes when compared to
usual care.

Public health relevance
Narrative Older surgical patients are at extremely high risk for cognitive and functional decline after hospitalization, and the COPE-iOS study is examining whether a comprehensive program of computerized cognitive training, guided progressive physical exercise, and health education performed throughout the entire perioperative period will improve long-term cognitive and disability outcomes in elderly surgical patients compared to active attention control. Multiple additional factors, including group social support which is provided in the COPE-iOS study, may influence postoperative recovery. The Investigating Functional Outcomes and Cognition thrU Surgery (InFOCUS) study is a prospective observational cohort measuring cognitive and physical outcomes after major surgery in older adults who are receiving usual care to allow better understanding of the efficacy of the combined cognitive and physical exercise program and further knowledge on potential contributions of enhanced systemic support around major surgery.